The Molecular Vector Physiology Laboratory at New Mexico State University

In the twelve years since its inception, the undergraduate, graduate, and post-graduate
researchers in the Molecular Vector Physiology Laboratory at New Mexico State
University have conducted basic and applied research projects resulting in major
contributions in the field of molecular and cellular physiology.
The laboratory team will continue to educate students and perform research to increase our
knowledge of the molecular physiology of mosquitos and other blood-sucking arthropod
disease vectors. Our research will focus on these areas:
• Nutrient signaling pathways and nutrient transport in the mosquito reproduction
model system.
• Regulation of water homeostasis and transport in mosquitos.
• Olfactory physiology of blood-sucking arthropod disease vectors.
• Development of novel methods of mosquito control.
Our research has the potential to improve the health and lives of people around the globe
by laying part of the foundation for the implementation of novel, ‘green’ strategies for the
control of mosquito populations and the diseases they transmit.

Public health relevance
This project is focused on the continuing operation of the Molecular Vector Physiology Laboratory at New Mexico State University, its research- and educational mission.